Amyloid-β Disruption of Pericyte Control of Capillary Hemodynamics

PROJECT SUMMARY
Alzheimer's Diseases—the most common cause of dementia in aging adults—is a slow, but progressive,
deterioration of the brain that leads to neurodegeneration and cognitive impairment. The classic
neuropathological sign of the disease is the accumulation of amyloid-β (Aβ)-containing plaques, which can
lead to neuronal damage when free Aβ oligomers form Ca2+-permeable pores, causing membrane
permeabilization and neuronal cell death. More recently, cardiovascular pathologies have been implicated in
the progression of Alzheimer's Disease and other forms of dementia. However, how these pathologies
contribute to the pathogenesis of Alzheimer's Disease is poorly understood; how vascular dysfunction
potentiates the failure to clear toxic Aβ from ageing brains. Our recent work provides evidence that
capillaries—the smallest vascular conduits and the point of nutrient delivery and waste removal blood and
surrounding neurons—act as a sensory network that detects and responds to neural activity by promoting an
increase in local blood flow. In addition, we observe that contractile ensheathing pericytes maintain the
efficiency of network perfusion by controlling blood flow at capillary junctions. In Preliminary Results, we
provide new evidence that Aβ peptide for Ca2+ permeable pores, leading to the increases of Ca2+ events in
contractile pericytes, but not in nearby vascular smooth muscle cells. In addition, we show that Aβ peptide-
mediated increases in the frequency of Ca2+ events lead to Ca2+ store depletion and inhibition of the voltage-
gated Ca2+ channels. We propose to test our overarching hypothesis that Aβ leads to the progressive loss of
pericyte function at capillary junctions leading to a reduction in capillary network perfusion efficiency, ultimately
affecting the health and function of surrounding neurons. The aims of the current study are 1) To test the
hypothesis that differences in membrane lipid environments enable free Aβ oligomers to form Ca2+-permeable
pores in capillary pericytes; 2) To test the hypothesis that free Aβ oligomers deplete internal Ca2+ stores,
leading to STIM1-mediated inhibition of voltage-gated Ca2+ channels; and 3) To elucidate the effects of Aβ
oligomers on local and regional blood flow. Successful completion of these studies is expected to provide
insights into how amyloid-β peptide accumulation disrupts blood flow within the microenvironment to negatively
impact neuronal vitality and provide therapeutic targets for the prevention of the neurodegeneration that leads
to cognitive impairment and dementia.

Public health relevance
PROJECT NARRATIVE Capillaries are the smallest vessels in circulatory system, yet make up majority of the vascular network and is the site of O2 and nutrients delivery and waste removal. The proposed work will test the hypothesis that amyloid-β (Aβ)—the major constituent of amyloid plaques in cerebral amyloid angiopathy and the brain of Alzheimer's patients— disrupts pericyte's control of local and regional capillary blood flow. As we gain a better understanding on of how blood flow is regulated within the microvasculature, pericytes represent a novel therapeutic target for cardiovascular and neurodegenerative diseases.